NCI NCTN-Network Lead Academic Participating Site at UPMC Hillman Cancer Center

Parent Award Abstract/Summary:
The goal of the National Clinical Trials Network (NCTN) Lead Academic Participating Site at UPMC
Hillman Cancer Center, is to increase our level of participation in conceptualization, development,
activation, performance, and reporting of the late-phase clinical trials of the NRG Oncology, ECOG-
ACRIN, and Alliance for Clinical Trials in Oncology Network Groups. This will be accomplished by
enhancing the quality of our scientific and administrative leadership; increasing accruals to NCTN
trials, with special efforts directed at minority, rural and other special populations; improving our
processes for rapid activation of new trials, with special efforts directed at trials for rare cancers
and genotypically-defined subpopulations; and mentoring junior investigators in how to conduct
phase 2 and phase 3 NCTN trials, and in the administrative, scientific, and interpersonal skills
needed for advancing into positions of leadership within the NCTN and National Cancer Institute.

Public health relevance
Project Narrative The goal of the National Clinical Trials Network Lead Academic Participating Site at UPMC Hillman Cancer Center, is to increase our level of participation in conceptualization, development, activation, performance, and reporting on the late-phase clinical trials of the NRG Oncology, ECOG-ACRIN, and Alliance for Clinical Trials in Oncology Network Groups.